Novel Markers of Treatment Responsiveness for Pediatric Acute Asthma Exacerbations

PROJECT SUMMARY
Acute asthma exacerbations are the primary cause of morbidity and mortality in children with asthma.
Current treatment for acute asthma exacerbations in the pediatric Emergency Department (ED) follows an one-
size-fits all approach including inhaled bronchodilators and systemic corticosteroids. However, treatment
response to initial protocolized therapies is variable and unpredictable presenting a significant management
challenge for ED clinicians. Unfortunately, the pathobiologic mechanisms driving treatment response remain
unclear, and an effective method to predict treatment response does not exist. Thus, ED clinicians frequently
struggle with treatment and disposition decisions leading to over-utilization of therapies, prolonged ED length
of stay, and hospitalizations in responders, and delays in appropriate therapy for non-responders. The
extensive variation and inefficiency in care highlights the critical need for tools to inform more precise and
effective ED management strategies for acute asthma exacerbations. The nasal transcriptome and airway
oscillometry (AOS) are novel biologic and physiologic markers with strong potential to address this unmet
knowledge and practice gap. This proposal aims to apply an innovative biomarker-directed, individualized
approach to ED asthma management by leveraging these novel markers to pursue the following specific aims:
1) determine the utility of AOS as an objective measure of ED treatment responsiveness; 2) identify airway
endotypes of ED treatment responsiveness using nasal transcriptomics, and 3) derive and internally validate a
clinical prediction rule incorporating clinical and historical factors, and biologic and physiologic markers to
determine ED treatment responsiveness in children with acute asthma exacerbations. To achieve these aims,
the candidate, Nidhya Navanandan, MD, will leverage an existing study infrastructure for enrolling children with
acute asthma exacerbations in the ED, developed in conjunction with her mentors during her institutional
career development award. As a pediatric emergency medicine physician, Dr. Navanandan is uniquely
positioned to accomplish the proposed K23 research and training aims. Her long-term goal is to become an
expert in clinical and translational research methods to improve the effectiveness of emergency care for
pediatric asthma. Dr. Navanandan has developed a detailed career development plan consisting of
mentorship, didactic coursework, and hands-on laboratory and research conduct experience in order to expand
her knowledge and skills in leadership of prospective studies, discovery and application of novel markers for
clinical practice, and predictive analytics. Dr. Navanandan has assembled a multidisciplinary team of mentors
with extensive clinical and translational research experience and topical expertise in the above realms to
ensure her success in achieving the stated specific aims and career goals. This proposal will allow Dr.
Navanandan to transition to an independent physician-scientist and prepare her for future R01-funding.

Public health relevance
PROJECT NARRATIVE This proposal will leverage an improved understanding of an individual’s biologic and physiologic response to emergent asthma therapies to inform biomarker-directed, individualized asthma therapy; a paradigm shift in the Emergency Department (ED) management of pediatric acute asthma exacerbations. A clinical prediction model incorporating clinical factors and objective markers of ED treatment response will be developed to guide clinical decisions, facilitate timely and appropriate therapeutic interventions and disposition decisions, and improve clinical outcomes for children acute asthma exacerbations.